Examining the Effects of Immulina to Increase Immune Resilience against Influenza Virus Infections

PROJECT 2: ABSTRACT/SUMMARY
The proposed University of Mississippi (UM) Botanical Dietary Supplements Research Center (BDSRC) is
focused on filling in knowledge gaps related to the potential for the Spirulina-based product, ImmulinaTM, to
promote resilience against and/or recovery from influenza and, by extension, other respiratory viral infections.
During the 2017-18 reporting year in the U.S. alone, influenza resulted in 959,000 patient hospitalizations and
79,400 deaths.
The UM BDSRC will be composed of an Administration Core, a Botanical Core, and two research projects.
Project 2, Evaluation of ImmulinaTM Oral Supplement for Host Resistance to Influenza Virus Infection, will be
directed by Gailen Marshall, MD, PhD, Professor and Executive Director of the Mississippi Clinical Research
and Trials Center at UM Medical Center. Working closely with him will be Khalid Ashfaq, PhD, DVM, DTVM.
Project 2 is designed to include studies utilizing both mouse models (Years 1-2) and biomarker-based
human models (Years 3-5) aimed at establishing the impact of ImmulinaTM supplementation on increasing host
resilience against the pathogenic effects of influenza virus infection. It will investigate the following
hypothesis: ImmulinaTM given in its optimal oral form will alter the host antiviral immune response, manifested
by increases in NK cell numbers and/or activity, anti-flu H and N antibody titers, and CD8+ cytotoxic T
lymphocytes (CTL) against flu-infected cells.
To investigate our hypothesis, we will achieve the following specific aims:
1. Evaluate oral administration of ImmulinaTM in three non-lethal mouse models of resilience against influenza
A virus infection (prophylaxis, prodrome and recovery) to determine the most effective utility of ImmulinaTM
for enhancing host immunity to improve antiviral resilience;
2. Confirm that activation of the TLR2 signaling pathway by Braun-type lipoproteins is a primary causal
mechanism through which ImmulinaTM enhances host immunity against antiviral infection;
3. Determine the optimal form and dosage of the ImmulinaTM-based supplement in the human model that will
maximize effects on increasing NK cell numbers and/or activity, increased supporting cytokines (IL-15, ILγ2, IGNg), influenza-specific antibody titers and CTL numbers;
4. Establish the timeline for optimal NK, cytokine, antibody and CTL responses in terms of both initial changes
and maximal changes and duration of the change once the ImmulinaTM is discontinued in normal and
immune compromised (elderly) human research participants; and
5. Examine the effects of routine influenzas vaccine given before, during, or after ImmulinaTM use to
investigate influenza antigen-specific immune responses in individuals receiving ImmulinaTM supplement vs
placebo.